Neural mechanism underlying corneal injuries by ammonia

Project Summary
Chemical injury of the eye is devastating and frequently leads to permanent eye damage or even
blindness. Among those chemical agents that cause ocular injuries, ammonia is known to cause most severe
corneal burns and related pain. Prevailing researches have suggested that ammonia impairs the corneal
epithelial wound healing via inflammation and damaging corneal basal epithelia cells or limbal stem cells.
However, the impacts of ammonia on corneal sensory fibers have not been characterized. We recently
discovered that ammonia can massively activate corneal sensory fibers upon exposure. We hence hypothesize
that over-activation of corneal sensory fibers by ammonia leads to nerve degeneration and contributes to
impairment of corneal wound healing.
To test this hypothesis, we will first use histochemical and transcriptomic studies to correlate the delayed
corneal wound regeneration with the extent of corneal nerve degradation in mouse models. The ocular pain
associated with ammonia exposure will be quantified by behavioral studies in mice (Aim 1). Results from these
studies will help define corneal damage caused by ammonia exposure and provide knowledge regarding
ammonia-induced corneal denervation in corneal wound healing.
Second, to delineate the activating mechanism of corneal sensory fibers by ammonia, we will conduct ex
vivo calcium imaging to characterize the sensitivity and response profiles of corneal sensory fibers to ammonia.
As over-activation of sensory fibers often leads to nerve degeneration, we will conduct genetic axonal tracing to
elucidate the changes of corneal sensory fibers over time after ammonia exposure and the role of various ion
channels of sensory fibers in responding to ammonia (Aim 2). Results from these experiments will provide the
critical link between the ammonia sensitivity and degeneration of corneal sensory fibers, shedding light on the
neural mechanism underlying ocular pain and corneal denervation by ammonia.
Third, we will investigate the effects of activity-dependent neuronal silencing in preventing over-activation
of corneal sensory nerves by ammonia, thereby attenuating ammonia-induced ocular pain and promoting corneal
wound healing (Aim 3). These studies will lead to a new and dual therapeutic strategy of using neural silencing
for ocular chemical burn.
In summary, the discovery that corneal sensory fibers are activated and then degraded by ammonia
opens a new research arena for corneal chemical burns. The proposed studies will not only reveal a previously
unrecognized neural mechanism behind corneal injuries by ammonia, but may also help develop novel
therapeutic strategies to alleviate ocular pain and corneal injuries by ammonia for the first time.

Public health relevance
Project Narrative Ammonia exposure causes the most severe chemical burns to the ocular surface. In this proposal, we will correlate the degradation of corneal sensory fibers by ammonia exposure with the impairment of corneal wound healing, which further leads to chronic corneal erosion and ulceration. Results from the proposed studies will fill the major gaps in our knowledge about the neuro-regulatory mechanism underlying corneal injuries by ammonia, and offer a new therapeutic strategy for ocular pain and injuries by ammonia.